Community Engagement Core

PROJECT SUMMARY
The proposed project seeks to leverage our extensive network of community partners within
the Black Belt region with the cancer genomic research and obesity studies proposed by RCMI
scholars to provide a multilevel evidence-based study that creates a data base that combines
genomic indicators with SDOH factors that will allow for more precise treatment modalities for
African American and Latinx populations residing the Black Belt regions.
The Community Engagement Core (CEC) advances methods for stimulating research
participation, recruitment, and participant retention through collaboration between community
residents and the RCMI research team. The CEC will implement the Total Cancer Care
Connect (CCC) Model to support the RCMI researchers and synergize data across Cores
utilizing the PhenX survey and social determinant of health indicators. The CEC will leverage
resources from community organizations to form a mutually effective link between CEC team
members and Black Belt Counties of Alabama. In addition, the CEC will engage undergraduate
and graduate students in education dissemination, social media marketing, and community-
based research methodologies that will equip them to pursue health disparities research as a
form of community activism and civic responsibility.